An integrated nano- and micro-indentation system for musculoskeletal tissue and biomaterials

Project Summary
The objective of this project is to purchase a Bruker Hysitron TI 980 TriboIndenter system (referred as the
TriboIndenter) for quantitative analysis of elastic modulus, hardness, and viscoelastic behavior of both
mineralized and soft musculoskeletal (MSK) tissues and biomaterials across multiple, small length scales. The
TriboIndenter will be located in the Biomechanics Core at the Penn Center for Musculoskeletal Disorders
(PCMD), a regional NIH-supported center in the Philadelphia region that provides critical resources, programs,
knowledge, and tools to MSK research communities at Penn and regional institutions. The requested
instrument is specifically chosen for the increased research interest and needs of the MSK research
community at Penn and the PCMD to address MSK tissue mechanical properties at nano-, micro- and meso-
scales. The requested TriboIndenter system has many state-of-the-art functions, including the integrated
Fluorescence Microscopy for accurate identification of test locations, the Electrochemical Indentation Cell that
enables hydrated testing conditions for biological specimen, the 2D dynamic modulus mapping functions, and
a wide range of force and indentation depths to accommodate materials that span several orders of magnitude
in tissue modulus. These powerful functions complement existing instrumentation and testing capabilities in the
Biomechanics Core at the PCMD to enable studies of both mineralized and soft MSK tissues across multiple
length scales. Acquisition of the proposed instrument will make this technology available to many investigators
(20 Major Users and 6 Minor Users). It will also remove barriers to major research projects impacting 26
currently funded NIH projects. In addition, it will aid 10 more projects funded by other federal and private
sources. The research that will benefit from this instrumentation promises to contribute to the translation of
basic biomedical research, MSK disease treatments, and injury repairs. This instrument will advance our
understanding of basic science and facilitate new therapeutic strategies against numerous MSK diseases and
conditions, including osteoporosis, osteoarthritis, rheumatoid arthritis, lower back pain, joint injury and
connective tissue tear and ruptures, fractures, and rare genetic conditions like mucopolysaccharidoses and
fibrodysplasia ossificans progressiva.

Public health relevance
Project Narrative This proposal requests funding for a Bruker Hysitron TI 980 TriboIndenter system for quantitative analysis of elastic modulus, hardness, and viscoelastic behavior of both mineralized and soft musculoskeletal tissues and biomaterials across multiple, small length scales. Properties of musculoskeletal tissues (bone, muscle, and soft fibrous tissues) at small length scales (nano, micro, and meso) are critical determinants of their mechanical function. Research using the TriboIndenter system will advance our fundamental understanding of musculoskeletal diseases and injuries and accelerate discoveries of new treatment strategies.